Building a Community-Based Mental Health Literacy Intervention for African American Young Adults

Project Summary/Abstract
Black/African American young adults are at elevated risk for trauma and related mental health concerns (e.g.,
PTSD, substance use) yet are less likely to engage in mental health care than other groups, due to substantial
and complex barriers to care. These disparities have been exacerbated by, and compounded with,
psychological and emotional distress due to the COVID-19 pandemic. Promoting mental health literacy (MHL),
defined as knowledge and beliefs related to mental health (e.g., recognition, prevention, and management of
symptoms) may be an important first step to improving mental health outcomes for Black/African American
young adults. This K01 Mentored Research Scientist Development Award will partner with a Community
Advisory Board to develop a community based MHL intervention, focused on trauma and substance use, for
Black/African American young adults. The culturally tailored intervention will be guided by the Theory of
Planned Behavior (TPB) and social ecological model as guiding frameworks, with intervention components
designed to promote TPB dimensions (i.e., behavioral, normative, and control beliefs related to mental health
care utilization) with resources at the individual, interpersonal, and organizational levels. Following
development, the intervention will be piloted among Black/African American young adults aged 18-35 years old
(N = 80), recruited from diverse community sites (e.g., colleges/universities, barbershops and hair salons,
churches, community organizations). Participants will complete a baseline survey assessing primary and
secondary outcomes (e.g., current MHL; stigma; beliefs, attitudes, and norms; history of mental health care),
with re-assessment mid-intervention and post-intervention. Post-study focus groups with intervention
participants (N = 30) will be held to elicit feedback on relevance, feasibility, acceptability, and satisfaction with
the intervention, to inform refinement and future dissemination efforts. Successful completion of the proposed
study will also benefit the PI, an early career researcher with goals to A) develop expertise in community
engagement and theoretically-driven translational research methods and B) build community capacity to
prevent mental illness, support recovery, and improve health outcomes with underserved and oppressed
communities. The PI is currently an Assistant Research Professor at Rutgers University at the Center of
Alcohol & Substance Use Studies, within the Graduate School of Applied and Professional Psychology. Her
long-term career goals include becoming a tenure-track, independent investigator; contributing to recruitment
and mentorship of underrepresented students; and advancing health and social equity for underserved and
minoritized communities.

Public health relevance
Project Narrative This K01 Mentored Research Scientist Development Award will partner with a Community Advisory Board to develop and pilot a community-based, theory-guided mental health literacy intervention for Black/African American young adults. Post-study focus groups with intervention participants will be held to elicit feedback on relevance, feasibility, acceptability, and satisfaction with the intervention to inform refinement and future dissemination efforts. The potential public health impact is large, as Black/African American young adults have low likelihood of engaging in mental health treatment despite elevated risk for exposure to trauma, subsequent mental health concerns (e.g., PTSD, substance use), and poor outcomes from untreated mental health conditions—particularly given the myriad psychological and emotional impacts of the Covid-19 pandemic.